A Role of Isolevuglandins in Essential Hypertension and Systemic Lupus Erythematosus

PROJECT SUMMARY
Essential hypertension and systemic lupus erythematosus (SLE) are devastating conditions for United States
Veterans. An estimated one-third of the world’s population suffers from hypertension despite a large number of
treatment options. SLE is a heterogeneous disease the treatment of which is limited to the use of non-specific
global immunosuppression. There is a lack of understanding of the mechanisms underlying these conditions.
Isolevuglandins (IsoLGs) are oxidation products of fatty acids that form as a result of reactive oxygen species.
These molecules adduct covalently to lysine residues of proteins. Adducted proteins are then presented as
autoantigens to T-cells resulting in immune cell activation and resultant hypertension and systemic autoimmunity.
Based upon previously published studies and preliminary data, it is clear that both essential hypertension and
SLE are initiated by this process of isoLG-adduct formation, processing, and immune cell activation. I have
discovered an important role of the immunoproteasome subunit LMP7 in the presentation of isoLG-adducted
autoantigens, the development of hypertension, and aortic inflammation in a mouse model of essential
hypertension. Additionally, in a mouse model of SLE, I have also discovered that treatment with an isoLG
scavenger, 2-hydroxybenzylamine, attenuates hypertension and systemic autoimmunity. Finally, I found that a
subset of patients with SLE exhibit isoLG accumulation within antigen presenting cells, suggesting a unique
clinical profile and potential therapeutic opportunities for these patients. I hypothesize that within antigen
presenting cells in both hypertension and SLE, isoLG adducts are processed and displayed by an
immunoproteasome dependent mechanism with a primary role of the immunoproteasome subunit LMP7.
Additionally, patients with SLE that exhibit isoLG-adduct accumulation exhibit unique disease characteristics. My
specific aims are: (1) To determine a role of isoLG-adducts in SLE-associated hypertension and disease
heterogeneity. (2) To determine the role of immunoproteasome function in isoLG-adducted antigen presentation
and hypertension. (3) To determine the role of LMP7 function in immune activation, isoLG-adducted antigen
presentation, and hypertension in SLE. To accomplish these aims we will recruit SLE patients and obtain
peripheral blood mononuclear cells. Cells will be studied by flow cytometry for the presence of isoLG-adduct
accumulation within unique populations of antigen presenting cells. IsoLG-adduct levels will be compared with
clinical parameters to determine the parameters that correlate with adduct accumulation. To study the function
of the immunoproteasome, I will utilize mice globally deficient for the three subunits of the immunoproteasome
(TKO mice). I have also generated a conditional knockout of the chymotrypsin subunit of the immunoproteasome
(LMP7fl/fl) which will be crossed to CD11c-Cre transgenic animals to generate an antigen presenting cell specific
LMP7 deficient animal. These animals will be studied for the development of hypertension and inflammation in
the setting of two well established acquired models of essential hypertension in mice. To study the role of LMP7
in SLE, I propose to examine the effect of the LMP7 inhibitor PR-957 in the B6.SLE123 murine model of SLE.
Additionally, I will study the effect of dendritic cell specific LMP7 deletion in a model of chemically-induced SLE
by treating LMP7fl/fl/CD11c-Cre with pristane. Animals will be studied for the development of hypertension,
immune cell expansion, autoantibody production, and renal injury. Together, these studies hold the promise of
elucidating novel mechanistic insights into essential hypertension and SLE. Moreover, they will provide novel
therapeutic opportunities for the treatment of these conditions.

Public health relevance
PROJECT NARRATIVE Hypertension and systemic lupus erythematosus (SLE) are autoimmune conditions that are devastating and for which there are no curative therapies. Hypertension is the most common risk factor for cardiovascular disease, which is the leading cause of death amongst US veterans. SLE affects nearly 20,000 veterans and is common among minorities and women, which are growing populations amongst US veterans. This project is designed to study the function of isolevuglandins, a product of reactive oxygen species, in both conditions. These discoveries are directly applicable to the design of novel diagnostic and therapeutic approaches for cardiovascular disease and systemic autoimmunity.